Induction and maintenance of SARS-CoV-2 mRNA vaccine-specific memory across tissues

PROJECT SUMMARY
Vaccines save lives, and the rapid development of novel vaccines against severe acute respiratory syndrome
coronavirus-2 (SARS-CoV-2) was a triumph for the medical community. While the rapid deployment of these
vaccines has undoubtedly attenuated the severe morbidity and mortality induced by the virus, their efficacy is
decreased against variant strains, in children, and with increasing time post-administration. These clinical
findings highlight our lack of understanding of how durable, protective immunity is induced by vaccination and
how this varies across the population. Studying vaccine induced memory in humans has two major challenges.
First, viral exposures over life confound the identification of vaccine-specific memory; second, the stores of
memory lymphocytes reside in the tissues, which makes monitoring the vaccine response in healthy individuals
challenging. The SARS-CoV-2 pandemic affords us the unique opportunity to study the response to a novel
vaccine formulation without confounding natural antigenic exposure and the ability to distinguish infection from
vaccination by serology. Additionally, our unique organ donor tissue resource provides a validated model to
investigate tissue-localized vaccine-specific immunity. The goal of this proposal is to understand how vaccine-
induced immune memory is distributed across tissue and affected by host factors such as age. The central
hypothesis of this proposal is that induction and maintenance of vaccine-specific memory is controlled in
lymph nodes, and specific early induction events directly impact immune memory development and
vary with age. I will address this hypothesis and meet the goals of the study by using flow cytometry and high-
dimensional sequencing to evaluate the relationship between circulating and tissue-localized vaccine memory
and how they differ in phenotype, function, and across age. I will also investigate how the initial, inflammatory
host-specific response to the mRNA-1273 vaccine differs across age and correlates to the quantity of immune
memory induced. The results of this study will elucidate the importance of lymph nodes in the vaccine
response and highlight the benefits and downfalls of mRNA vaccines across various host factors. These
results will have implications for future vaccine design and may play a role in managing both the SARS-CoV-2
pandemic and any future ones.

Public health relevance
PROJECT NARRATIVE Vaccines are necessary to protect against harmful pathogens; however, their development has typically been empiric and their approval based on clinical, not immunological outcomes. The severe acute respiratory syndrome coronavirus-2 (SARS-CoV-2) mRNA vaccines demonstrate varied efficacy across age and time post-vaccination, highlighting our lack of understanding of how, where, and in what quantity vaccine-specific immunity is induced. This proposed work will fill these gaps in knowledge so that more effective prevention strategies can be developed to manage the current pandemic and any future health crises.